Mass Multivariate Derivation and Validation of AUD Biotypes using Developmental Imaging and Genomic Approaches

PROJECT SUMMARY/ABSTRACT
In stark contrast to the widespread prevalence and devastating outcomes associated with alcohol use disorder,
currently available treatment options are only moderately effective. The large heterogeneity in AUD presentations
may obfuscate etiology and individualized treatment options. In this 5-year K01 mentored research scientist
award application, I propose to characterize the behavioral, molecular, and genetic correlates of AUD biotypes
(subtypes determined by biology) across the lifespan. To this end, I will apply semi-supervised machine learning
algorithms to structural brain imaging data from the largest available AUD and alcohol use datasets from
childhood to old age (total n=61,428). I will examine the stability of these biotypes across the lifespan, including
among substance-naïve children and adults with heavy alcohol use, as well as their correlates with
neurobehavioral stage-based constructs of addiction (i.e., impulsivity, negative affect, cognition) and with alcohol
involvement trajectories. I will then conduct a genome-wide association study of AUD biotypes to disarticulate
their genetic architecture, genetic correlates, and potential molecular pathways that may be leveraged for drug
repositioning. This grant develops my skillsets in semi-supervised machine learning, AUD heterogeneous
presentations, multivariate genome-wide methods, and multi-omic analytic approaches. These skill sets will
serve as a backdrop for a planned R01 submission that will leverage my background in large-scale data analysis
to translate across biological modalities in substance use research.

Public health relevance
PROJECT NARRATIVE The heterogeneity of alcohol use disorder (AUD) may contribute to the limited effectiveness of treatments. Here, I explore AUD biotypes (subtypes determined by biology) derived from MRI data and characterize the behavioral, genetic, and molecular correlates of these biotypes across the lifespan, as well as their correlates with alcohol involvement trajectories. Parsing and characterizing the biological heterogeneity of AUD may lead to improved personalized treatment options for patients through drug repositioning.